A novel glutaminase-free mammalian asparaginase with minimized immunogenicity to enable expanded use in cancer therapy

Project Summary: Enzyme by Design (EbD) is developing a safer asparaginase (ASNase) to maximize the
potential clinical applications of this unique drug. ASNases are enzyme drugs that systemically deplete
asparagine from the blood. In the US, the 1st-line ASNase is Oncaspar, a PEGylated version of the E. coli
ASNase (EcA). Patients intolerant of Oncaspar switch to the naked Erwinia ASNase (ErA, Erwinaze). Despite
being key drugs in pediatric acute lymphoblastic leukemia (ALL), the side effects of current FDA-approved
ASNases are so pronounced in adults that their use is largely avoided. These side effects also prevent the use
of ASNases in acute myeloid leukemia (AML) and in pancreatic, ovarian or triple-negative breast cancers,
despite strong evidence that ASNases would be effective in treating those cancers. Side effects of EcA/ErA stem
from i) their immunogenicity, due to their bacterial origin and ii) their glutaminase (GLNase) co-activity. To
expand the use of this drug to adult ALL patients and to other indications, there is a strong need for an ASNase
with (i) reduced immunogenicity, (ii) lack of GLNase co-activity, combined with (iii) long in vivo persistence.
To mitigate the immunogenicity, EbD is developing the first mammalian ASNase from the guinea pig (GpA) that
is much closer in identity to the human ASNase compared to the bacterial EcA/ErA. To reduce the immunological
risk even more, we employed a structure-guided strategy to humanize GpA, generating GpAhum. An added
advantage of GpAhum is that it is intrinsically GLNase-free, thereby reducing off-target drug toxicity. EbD
successfully delivered the following STTR Phase 1 milestones: 1) 11 site-specific PEGylated versions of GpAhum
were developed to increase its half-life and the best variant, PEG-GpAhum with ~3-fold increase in t1/2 was
identified. 2) in T-ALL mouse xenograft models, PEG-GpAhum q.wk was more potent than GpAhum t.i.w, and 3)
most importantly, benchmarking our molecule against the market leader, a strikingly undeniable superior toxicity
profile of PEG-GpAhum vs. Oncaspar in both single and repeat dosing studies was observed, greatly de-risking
PEG-GpAhum in the development pipeline.
Our completed I-Corps programs with >130 interviews with leaders and stakeholders in the ALL field validated
the expected adoptability of PEG-GpAhum, becoming best-in-class. This molecule would deliver similar
therapeutic efficacy with reduced dosing frequency and total amount of drug injected, predicting less
accumulated toxicity in patients, lowered drug-related therapy cost and increased ease of use. This SBIR Phase
2 proposal will 1) develop appropriate GMP scale-up manufacturing protocols for PEG-GpAhum, 2) advance it
through key IND-enabling studies and 3) confirm a viable biomarker for patient stratification, using AML as the
first example of expanded indication. Future SBIR Phase 2b will support the completion of the IND application
package and GMP material for clinical use. Successful development of PEG-GpAhum will supply a much safer
ASNase drug with immediate clinical implications for ALL and likely future expansion to additional indications of
unmet need.

Public health relevance
Project Narrative: L-asparaginases (ASNases) are critical drugs for acute lymphoblastic leukemia (ALL) with great potential use in other cancers, but (i) the immunogenicity and (ii) the L-glutaminase (GLNase)-related toxic side effects of current bacterial ASNases often forces halting of treatment in pediatric ALL patients; mostly precludes their use in adult ALL patients and prevents their application in other cancers including acute myeloid leukemia (AML). We developed a long-acting version of a mammalian GLNase-free ASNase, allowing persistent asparagine depletion at lower doses and less frequent drug administrations, but most importantly its low immunogenicity and free of GLNase-related complications make it a safer ASNase eligible for expanded indications in cancer therapy. This proposal will 1. develop an appropriate manufacturing protocols for the lead biologic, 2. advance it through key IND-enabling studies and 3. identify a patient stratification strategy for its use in AML.